Bupe by the Book: Developing and Testing a Tele-Buprenorphine Intervention in Public Libraries with Unstably Housed Persons with Opioid Use Disorder

Bupe by the Book: Developing and Testing a Tele-buprenorphine Intervention in Public
Libraries with Unstably Housed Persons with Opioid Use Disorder
Abstract
Public libraries nationwide are experiencing an on-premise opioid overdose crisis. Buprenorphine
“bupe” is a highly effective medical treatment for OUD, but many unstably housed persons at
libraries lack access to bupe due to structural barriers. “Bupe by the Book” (BBB), in collaboration with
our established local partners, San Diego Public Libraries and Father Joe's Village Health Center (FJV),
would innovatively adapt FJV's already successful same-day, free low barrier tele-bupe treatment to
library settings. By testing tele-bupe uptake and retention in libraries, this study will inform how
individuals can receive bupe care in innovative low-barrier ways, potentially changing the landscape
radically for implementing bupe. Our three aims are:
1) Develop and refine “Bupe by the Book” (BBB) within the Technology Acceptance Model
(TAM): Through focus groups and intervention mapping techniques, we will: a) assess the perceptions
of stakeholders such as local residents with children who use the library, library staff, tele-bupe
providers, and persons with OUD about BBB's potential, b) develop a plan with stakeholder input, and c)
identify modifiable barriers to implementation.
2) Determine the feasibility of BBB and measure treatment uptake and adherence: We will
conduct a 12-week pilot 2-arm randomized controlled trial (RCT) (n=40). Study staff will recruit library
patrons and randomize them to weekly tele-bupe at the library or in-person clinic control arms. A health
provider will then screen participants for eligibility for same-day bupe induction. BBB's effects on bupe
induction and adherence to prescribed doses will be based on self-reported measures at 1-,2-,4-,8-,12-
week follow-ups with study staff, and weekly urinary drug screenings and prescription pickups. We
hypothesize that tele-bupe in the library vs. the control group will have higher uptake and longer
adherence to treatment. This pilot will provide estimates of uptake and adherence for the design of a
larger trial of the intervention's efficacy.
3) Evaluate the acceptability of BBB and identify program components that could be improved
to enhance adherence and patient satisfaction. We will conduct structured interviews with BBB
patients, health providers, and library staff to gain insight into the patients' experiences with BBB
compared to in-person clinic-based bupe treatment.
By utilizing multiple library sites, we will render tele-bupe reproducible for other libraries nationwide
facing opioid overdoses and pave the foundation for a larger RCT in a subsequent R01 to evaluate the
efficacy of utilizing public settings to treat substance use disorders and reduce opioid-related deaths.

Public health relevance
PROJECT NARRATIVE Public libraries nationwide are experiencing an on-premise opioid overdose crisis. U.S. overdose deaths increased 30% in 2020, with many persons with opioid use disorder (OUD) remaining unhoused and profoundly hard to reach. Therefore, this study will be the first to develop and test a telehealth intervention delivered through public libraries to reduce opioid-related deaths by increasing unstably housed individuals’ buprenorphine medication access and adherence.